J: Penn State NRSA Training Core

Contact PD/PI: Sinoway, Lawrence Isaac NRSA-Training-001 (003) 2!.3,!4)/. /& 3#)%.4)&)# $)3#/6%2)%3 ).4/ %&&%#4)6% #,).)#!, ).4%26%.4)/.3 !.$ %34 02!#4)#%3 4/ )-02/6% 05,)# (%!,4( )3 ! #/-0,%8 02/#%33 42!.3#%.$).' 42!$)4)/.!, $)3#)0,).%3 (% '/!, /& 4(% %.. 4!4% ,).)#!, !.$ 2!.3,!4)/.!, #)%.#% .34)454% 2!).).' /2% )3 4/ 02/6)$% %!2,9 #!2%%2 3#)%.4)343 7)4( 4(% ).4%2$)3#)0,).!29 42!).).' .%%$%$ 4/ #/.$5#4 #/,,!/2!4)6% 42!.3,!4)/.!, 2%3%!2#( !)-%$ !4 42!.3&/2-).' +./7,%$'% 4/ %.%&)4 (5-!. (%!,4( 52 02/'2!- 02/6)$%3 /00/245.)4)%3 &/2 02%$/#4/2!, 42!).%%3 4/ '!). ! &/5.$!4)/. ). #,).)#!, !.$ 42!.3,!4)/.!, 3#)%.#% 4(2/5'( #/-0%4%.#9 !3%$ $)$!#4)# %80%2)%.4)!, -%.4/2%$ 42!).).' /00/245.)4)%3 #/50,%$ 7)4( #!2%%2 $%6%,/0-%.4 !#4)6)4)%3 2!7).' 345$%.43 &2/- /4( 4(% /,,%'% /& %$)#).% / !.$ .)6%23)49 !2+ #!-053%3 4(% 02/'2!- )3 ! &/25- &/2 #/--5.)#!4)/. #/,,!/2!4)/. !.$ #2/33 &%24),):!4)/. /& )$%!3 !-/.' 345$%.43 &2/- $)6%23% !#+'2/5.$3 !.$ $)3#)0,).%3 ).#,5$).' )/-%$)#!, 3#)%.#%3 -%$)#).% .523).' .542)4)/.!, 3#)%.#%3 )/%(!6)/2!, !.$ 3/#)!, 3#)%.#%3 !.$ )/%.').%%2).' . 4(% 0!34 &5.$).' #9#,% 7% 42!).%$ 345$%.43 ). /52 9%!2 ,/.' 02/'2!- ( ( !.$ 345$%.43 ). /52 35--%2 02/'2!- ( . 4()3 2%.%7!, !00,)#!4)/. 7% 2%15%34 3500/24 &/2 9%!2 ,/.' 42!).%%3 !.$ 3(/24 4%2- 42!).%%3 0%2 9%!2 2!).%%3 ). 4(% 9%!2 02/'2!- 05235% 345$)%3 ,%!$).' 4/ ! #%24)&)#!4% ). 2!.3,!4)/.!, #)%.#% ! ). ,).)#!, %3%!2#( /2 ! 5.)15% $5!, 4)4,% ( ). ,).)#!, !.$ 2!.3,!4)/.!, #)%.#%3 2!).).' )3 #534/-):%$ 6)! ).$)6)$5!, $%6%,/0-%.4 0,!.3 !.$ %.(!.#%$ 9 %84%2.3()03 !.$ %80%2)%.4)!, #,).)#!, 2%3%!2#( $%6%,/0-%.4 /& ,%!$%23()0 #/--5.)#!4)/. !.$ 4)-% -!.!'%-%.4 3+),,3 !.$ !#4)6)4)%3 &/#53%$ /. 4%!- 3#)%.#% %.42%02%.%523()0 2%'5,!4/29 3#)%.#% !.$ #/--5.)49 %.'!'%-%.4 3(/24 4%2- 42!).).' )3 /&&%2%$ ). 35--%2 4/ ! -)8%$ #/(/24 /& -%$)#!, !.$ '2!$5!4% 345$%.43 7(/ !2% ).42/$5#%$ 4/ 4(% &5.$!-%.4!, !30%#43 /& ). ! ()'(,9 ).4%2!#4)6% &/2-!4 7(),% #/.$5#4).' -%.4/2%$ 2%3%!2#( 02/*%#43 % ./7 3%%+ 4/ %.(!.#% 4(% 02/'2!- 7)4( !)-3 4/ 80!.$ !.$ %.(!.#% %.. 4!4%;3 #/--5.)49 /& 02%$/#4/2!, 42!).%%3 %.'!'%$ ). 9 ).#2%!3).' $)3#)0,).!29 2!#)!, %4(.)# !.$ /4(%2 %,%-%.43 /& $)6%23)49 /& 42!).%%3 9 7/2+).' 7)4( 4(% $)2%#4/23 /& %8)34).' 5.$%2'2!$5!4% 0)0%,).% 02/'2!-3 !.$ 9 $%6%,/0).' ! .%7 ).4%2.!, 0)0%,).% 02/'2!- 4/ )6%23)&9 %3%!2#( 2!).).' ). ,).)#!, !.$ 2!.3,!4)/.!, #)%.#%3 ) % 2/6)$% #534/-):%$ #/-0%4%.#9 !3%$ $)$!#4)# !.$ %80%2)%.4)!, 42!).).' 4(2/5'( %84%2.3()03 !.$ 42!).).' ). #/,,!/2!4)6% 4%!- 3#)%.#% #/50,%$ 7)4( #!2%%2 $%6%,/0-%.4 !#4)6)4)%3 3425#452%$ -%.4/2 -%.4%% 42!).).' !.$ .%47/2+).' !#4)6)4)%3 !#2/33 53 7)4( 3(!2%$ ).4%2%343 ). 252!, (%!,4( !.$ (%!,4( $)30!2)4)%3 !.$ .#2%!3% 4(% 15!,)49 !.$ %&&%#4)6%.%33 /& /52 42!).).' 9 53).' ! $!4! $2)6%. $%#)3)/. -!+).' !002/!#( ).6/,6).' !33%33-%.4 /& 4(% 42!).%%3 4(%)2 -%.4/23 !.$ 02/'2!- /54#/-%3 ).#,5$).' 6)! #/--/. -%42)#3 Project Summary/Abstract Page 1286 Contact PD/PI: Sinoway, Lawrence Isaac NRSA-Training-001 (003) 4 (( -- $ .--) &$( ),, (-& + #) ( .' 8(+;(:, +;*(:065 -68 :/, ;:;8, ,= 6+,39 (5+ ,:/6+9 -68 :/, 3050*(3 (5+ $8(593(:065(3 &682-68*, # $ #$ !! + #. ( )(()+ 0 & 32% %# + 996*0(:065 6- 865 ,-0*0,5*? 5,40( &0:/ ,(805. 699 05 %# +;3:9 %! #( ! &# #$ !! + )(()+ 0 & 32% %# + $/, ,3(:0659/07 ,:=,,5 865 ,-0*0,5*? 5,40( (5+ #,596805,;8(3 ,(805. 699 05 :/, !,+0(:80* (5+ +63,9*,5: !67;3(:065 & ! #$ !! + +.!!2 ., # + )&-.( ) #.' && # + ,+;*,+ :6:(3 9,8;4 )0308;)05 3,<,39 (8, (996*0(:,+ =0:/ ;3*,8(:0<, *630:09 ! , + .* (,* + + 0 - / (, ;3:0468)0+0:? 6- 6<,8=,0./: (5+ 6),90:? (365.90+, (5>0,:? (5+ +,78,990<, +0968+,89 05 05+0<0+;(39 =0:/ 9705(3 *68+ 051;8? !# #$ !! + - +, $ #- + ) 0 & 32% 5*68768(:05. 5-684(:0*9 -68 5:,.8(:05. 0636.? (5+ :/, ,+90+, 0 ) 05:6 !8,+6*:68(3 $8(05,, ;880*;3;4 :6 <(3;(:, #:;+,5: ,5,8(:,+ ?76:/,9,9 # $ + .* (,* + + )+ 2 .++$,$ / (, 5+0<0+;(39 =0:/ 9705(3 *68+ 051;8? /(<, .8,(:,8 6++9 6- 9;)9:(5*, ;9, +0968+,89 :/(5 565 9*0 *647(809659 #& ! ! )# + )* 0 && #.&3 )(-)+$ )-3, # / + .1 & ).+( + &-' ( )(,)+- # $ ,>73(5(:065 (5+ ,3()68(:065 ;7+(:,+ .;0+,305,9 -68 8,768:05. 7(8(33,3 .86;7 8(5+6409,+ :80(39 % &# (( -- &$( /$( $(& 2 633()68(:065 (5+ $,(4 #*0,5*, 0,3+ ;0+, ,:/,9+( (:065(3 59:0:;:,9 6- ,(3:/ . $) 2)0,%$ )+' ( ;3:0 !865.,+ 7786(*/ :6 0<,890-?05. :/, &682-68*, % ' #! $ & % +-$( .-+$ + 0$, 9;9:(05()3, *6;89, 05 8,9,(8*/ 4,5:6805. # $ !.( + ( # 0 ( &,' ( 5:,805. ,5:6805. 5+ +0:065 5:,805. ,5:6805. #,80,9 ,= '682 ' & 8,,4(5 6 ) +, )+%( ,, * ( + !.( 5*8,(905. 8,9,(8*/ 4,5:68 :8(0505. (465. )064,+0*(3 8,9,(8*/,89 (: 3050*(3 (5+ $8(593(:065(3 #*0,5*, =(8+ /;)9 $/, 047(*: 6- :/, -(*030:(:68 :8(0505. 050:0(:0<, # $ + $ - '' . + $, # + ,5:6805. 786.8(49 -68 4,+0*(3 9:;+,5:9 ( 8,<0,= 6- :/, !;) ,+ 30:,8(:;8, & & '$( )., (,)( . + .-- +) (% $( . $) $/, ,5:6805. 647,:,5*? 99,994,5: <(30+(:065 6- ( 5,= 059:8;4,5: :6 ,<(3;(:, 920339 6- 8,9,(8*/ 4,5:689 &$ % & $( &# $ ! & % $ $ !!#%& % $ ,= '682 ' #7805.,8 References Cited Page 1287